Developing a therapeutic, music-based mobile application to combat neuropsychiatric symptoms in people living with Alzheimer's disease and related dementias

Project Summary
More than 6 million people in the United States are living with Alzheimer’s Disease and Related
Dementias (ADRD). Music-based interventions have been shown to decrease common ADRD
behaviors (agitation, depression) through melody and tempo to modulate parasympathetic
nerve activity, which leads to changes in heart rate, music-induced relaxation/movement, and
enhanced mood regulation. Since many music interventions are only available in institutional
settings, family caregivers often lack resources and have limited access to digital-based
applications to deliver an intervention while providing informal care for their loved ones at home.
In this proposal, we will develop, a mobile application, “Tune Den,” created specifically for the
use by people with ADRD supported by their family caregivers. Tune Den's unique design
tailored for people living with ADRD and their family caregivers is expected to have a therapeutic
benefit for the users and to reduce neuropsychiatric symptoms and change activity levels.
Therefore, the overall impact of this app could prevent or delay pharmacological interventions.
The proposed aims describe our development of app: (1) Tune Den will be created to respond to
changes in heart rate and sedentary behaviors in a wearable device based on movements of
people with ADRD. Depending on the assessment of an individual’s preferred songs and
physiological signal response to those songs, the app will learn participants’ responses and
begin to auto-play playlists, titrating the music dose based on physiological reactions. The
musical experience will be personalized to either positively stimulate or soothe and relax. (2)
We will test the usability of the app. We will recruit an advisory committee of social workers and
music therapists to test the app for two weeks. The stakeholders will report feature functionality
using the Usefulness, Satisfaction and Ease of Use questionnaire. Focus groups will be held to
expand stakeholder’s perception on the acceptability of the app. (3) We will determine the
performance and usability of the app for use by people with ADRD and their family caregivers
providing care at home. Thirty dyads will be recruited to test Tune Den for two weeks. Following
the testing period, family caregivers will complete the USE survey and rate key features like
auto play and music dose. Our study team has expertise in music therapy, aging and neuro-
rehabilitative technologies, and older adults living with dementia and family caregiving. The
successful completion of Phase I will lead to a Phase II study to determine the clinical efficacy of
Tune Den in which we will perform a rigorous trial.

Public health relevance
Project Narrative Despite the promise of music and technology-based interventions, there lack mobile applications that are specifically designed for use by caregivers of individuals with ADRD and currently there is no device available that will provide immediate relief with the proper dose of music for agitation or apathetic behaviors accompanied by ADRD. A mobile application will be created specifically for the use by people with ADRD supported by their family caregivers to detect heart rate and movement and will be prompted to trigger auto-play of songs, titrating dose based on physiological reactions. It is expected that the proposed application will extend the evidence-based benefits of music in millions of homes for people living with ADRD as a therapeutic by reducing agitation and depression symptoms, which remain a burden for both individuals with ADRD and their family caregivers.